INCREASED INCIDENCE OF PULMONARY HEMORRHAGE/HEMOSIDEROSIS IN INFANTS

The objective of the parent study is to investigate possible causal mechanisms associated with an increased incidence of idiopathic pulmonary hemosiderosis in a geographic cluster area in the eastern Cleveland metropolitan area. In the process of the investigation by the Centers for Disease Control and Prevention, several lines of evidence point toward an etiological role of mycotoxins from an unusual fungus, Stachybotrys chartarum. Extensive environmental sampling of patient and control homes, done by NIOSH, found this fungus in all but one of the 12 patient homes studied and in 16 of 29 control subject homes. The purpose of this addendum involving the GCRC is to further investigate control subjects who are at-risk for pulmonary hemosiderosis due to Stachybotrys in their homes. The followup exams have been completed and the data is in analysis.